TNFRSF13B polymorphisms and immunity to transplantation

Abstract:
The proposed research investigates how genomic polymorphism of the TNFRSF13B
locus predicts and potentially governs the immune response to and outcomes of
transplantation. The investigators (de Mattos Barbosa et al., 2021) recently found that
non-synonymous mutations of TNFRSF13B occur 5-fold more frequently in kidney
transplant recipients that develop antibody-mediated rejection than in recipients with
persistently healthy grafts. The working hypothesis of this application is that TNFRSF13B
polymorphism shapes B cell responses to allotransplantation in ways that determine
pathogenicity of the responses. Since affinity-maturation, kinetics, self-non-self
discrimination and persistence of elicited antibody production have been connected with
TNFRSF13B function, these characteristics will be evaluated in allo-specific B cells
isolated from kidney transplant recipients. Because TNFRSF13B is among the most
polymorphic genes in humans and other mammals, the proposed research will draw on
diverse pools of kidney transplants already enrolled in the Michigan Genomics Initiative,
and in the NIH APOLLO study to connect genotypes with transplantation outcomes. The
results obtained with these cohorts will be verified by analysis of genotypes and outcomes
of subjects in two major NIH studies, DeKAF and GEN03. The large number of kidney
transplant recipients enrolled in the aforementioned studies will provide a vast pool from
which the phenotype and implications for transplantation of the most common allelic
TNFRSF13B variants can be identified. The functional properties of the most important
TNFRSF13B alleles in turn will be confirmed and the mechanism ascertained by
engineering tnfrsf13B mutations in mice and testing B cell functions and outcomes of
heterotopic cardiac allotransplants.

Public health relevance
The proposed research investigates how genomic polymorphisms of TNFRSF13B predict and potentially govern the character and outcome transplantation immunity in humans. We will determine whether allelic TNFRSF13B variants of known phenotype engender donor-specific B cell responses to organ allografts and the association of those responses with transplant outcome. The functional properties of the most important TNFRSF13B alleles will be confirmed and the mechanism ascertained by engineered tnfrsf13B mutations in mice and testing such mice as recipients of heterotopic cardiac allografts.